16th International Congress on Toxoplasmosis

PROJECT SUMMARY: The organizers of the 16th International Congress on Toxoplasmosis and Toxoplasma
gondii Research request support for this meeting, which will occur in May 2022, after a 1 year pandemic-re-
lated delay. Toxoplasma gondii is a ubiquitous, protozoan parasite that is transmitted through contaminated
food and water. Subclinical toxoplasmosis infects up to 1/3 of the world’s population. In the
immunosuppressed, the parasite can be fatal and causes encephalitis and blindness. This biennial meeting
brings together clinicians and principal investigators, graduate students, and postdoctoral fellows from labora-
tories engaged in Toxoplasma research worldwide. The main program will consist of non-concurrent short
talks, selected from submitted abstracts and organized thematically with evening poster sessions. The strength
of this meeting is that it brings together researchers from different disciplines who rarely attend the same meet-
ings. These groups include parasite cell and molecular biologists, immunologists, clinical investigators, industry
researchers, and representatives of governmental regulatory and public health agencies. The breadth of these
topics will be covered by the following five categories: Parasite Cell Biology; Epidemiology, Clinical, and Envi-
ronmental Science; Immunology; Host-Parasite Interactions; and Genomics and Population Biology. As in prior
meetings, attendees will be encouraged to present unpublished work, and particular attention will be paid to
ensuring that early career scientists are highlighted. The aims of this meeting are to: disseminate pioneering
research and technology to the field to increase cross-disciplinary collaborations (Aim 1) and support the ca-
reers of trainees and junior investigators in STEM, including those from historically marginalized communities
(Aim 2). Aim 1 will be accomplished through a diverse range of sequential sessions that encourages discus-
sion; the sharing of unpublished data across disciplines through talks and poster sessions; networking events;
and two pre-meeting workshops. In addition, to disseminate the scientific content to those who could not attend
the meeting, mSphere will publish a summary of meeting highlights, and talks will be posted online. Aim 2 will
be accomplished by selecting talks from submitted abstracts which encompass all scientific levels (graduate
students, postdoctoral fellows, PIs); increasing the visibility of Junior PIs through their selection as session
chairs; a Career Development Workshop for trainees that will highlight the vast array of career options availa-
ble to those with advanced scientific training; and, for the first time at this conference, an Outreach Event for
AP Biology High School students from a local school district with a high percentage of minoritized students.
The funds requested in this grant will 1) facilitate travel and registration for new investigators from geo-
graphically underrepresented regions, 2) subsidize travel for graduate students and postdoctoral fellows (~30%
of meeting attendees), and 3) support childcare/dependents grants; all of which are critical to maximize our
ability to diversify our attendees and make our conference fully inclusive.

Public health relevance
PROJECT NARRATIVE Toxoplasma gondii is a ubiquitous, protozoan parasite that is transmitted through contaminated food and water, and subclinical toxoplasmosis is one of the most prevalent human parasitic infections, infecting up to a third of the world’s population. In immunosuppressed patients, the parasite can cause devastating disease including encephalitis, blindness, and even death. The 16th Biennial International Congress on Toxoplasmosis and Toxoplasma gondii Research (May 2022) brings together clinicians and principal investigators, graduate students, and postdoctoral fellows from laboratories engaged in Toxoplasma research worldwide with the goal of sharing clinical and scientific breakthroughs to improve outcomes for patients with toxoplasmosis and to empower the next generation of Toxoplasma researchers.